Regulation of T cell immunity

Project Summary
Background and Innovation: Mortality from infectious diseases remains the second leading cause of death
worldwide, a fact highlighted by 4 years of a global pandemic, making the understanding of host responses,
development of new vaccines, and improving existing vaccines important priorities of biomedical research.
Memory T cells mediate protection from reinfection with previously encountered pathogens, and a large
number of these cells, termed tissue-resident memory cells (TRM), do not recirculate throughout the body,
reside within tissues, and provide essential sentinel protection at body surfaces. Using a murine infection
model that is well established in the field for studying CD8 TRM, this application will investigate the context- and
tissue-specific roles of the transcription factor Foxo1. Conceptual innovations include the study of Foxo1, the
role of which is poorly understood in TRM biology. Technical innovations include the use of numerous cutting-
edge approaches, including Cellular Indexing of Transcriptomes and Epitopes (CITE-seq) which enables
proteomic and transcriptomic (scRNA-seq) analyses in the same single-cells, to identify consequences of
Foxo1-deficiency in TRM. Bioinformatic innovations include the application of Taiji, a state-of-the-art
bioinformatic analysis algorithm integrating transcriptomic and epigenomic data, to reveal Foxo1-transcription
factor networks and identify putative regulatory factors and pathways controlled by Foxo1.
Significance and Impact to Veterans Healthcare: Infectious diseases have a substantial public health and
economic burden on the Veteran population. These include diseases for which we have vaccines, such as
SARS-CoV-2 and influenza, as well as diseases that we do not yet have vaccines for, such as Hepatitis C
(HCV) and HIV. A major gap in knowledge is that current vaccines generate neutralizing antibodies but do not
generate a robust memory T cell response, including TRM, which are crucial for optimal protection at barrier
surfaces. Another gap in knowledge is a comprehensive molecular understanding of the tissue-specific
requirements for the generation and persistence of TRM, which will be addressed by this project. This research
will address the VHA/ORD research priority of exploring fundamental biologic principles in pre-clinical models
with the ultimate goal of improving the well-being of the nation’s Veterans specifically in the area of infectious
diseases.
Path to translation/implementation: Current vaccination regimens aim to generate protective antibodies but
do not generate TRM. A detailed understanding of regulatory programs and transcriptional networks that govern
T cell adaptation to tissues and barrier sites must be gained in order to provide the foundation and rational
scientific basis to develop “tissue-tailored” immune responses. In this way, immune cells that promote or
regulate inflammation can be transcriptionally engineered for trafficking to, retention in, and function within a
particular tissue. Next steps to move this research along the translational pathway will involve testing whether
modulation of Foxo1-mediated pathways enhances vaccine-generated immune memory.

Public health relevance
Infectious diseases contribute to significant morbidity and mortality in the Veteran population. Memory CD8 T cell populations that reside in organs, termed tissue-resident memory cells (TRM), provide sentinel protection at mucosal surfaces and within tissue compartments and are among the key first responders in many infection settings. This proposal aims to elucidate the distinct roles played by the transcription factor Foxo1 in key aspects of TRM biology across organs, which may inform the design of therapeutic strategies that modulate TRM in order to benefit human health.